RNA and DNA sensors in the response of macrophages to ionizing radiation

Project Summary
Exposure to ionizing radiation (IR) is associated with inflammation due to an upregulation of inflammatory
mediators and hyperactivity of the cells responsible for their production. The key immune cells involved in IR-
induced inflammation, both as exacerbators and extinguishers, are macrophages (MΦ). Thus, deciphering of
the signaling mechanisms responsible for IR-induced activation and polarization of these highly radioresistant
cells is important for the identification of therapeutic targets to manage acute and counteract chronic IR-
related inflammation. Along with damage-associated molecular patterns, released from irradiated tissues,
radiation itself directly impacts MΦ through DNA damage and modulation of transcription that alters the MΦ
phenotype. This effect is implemented through the activation of specific DNA and RNA sensors and
downstream signaling pathways, resulting in differential expression of type I interferons (IFN-I) and interferon-
stimulated genes (ISGs). It is well established that DNA fragments activate the STING/TBK1 pathway,
thereby triggering IFN-I expression. However, we recently demonstrated that the cytoplasmic RNA sensors,
RIG-I-like receptors (RLRs) and their adaptor protein MAVS, also play a significant role in MΦ activation after
IR. We found that activation of the RLR family member MDA5 by double-stranded RNA, due IR-induced
transcription of endogenous retroviruses (ERVs), leads to increased expression of IFN-I and inflammation-
related genes. This finding generates two important questions that need to be resolved. First, whether the
signaling from RLRs is critical for prolonged IR-induced activation of MΦ. Our data that ERV RNA-induced
MDA5 signaling and IFN-I expression, in turn, upregulates retroviral transcription, suggests that there is a
positive feedback loop for ERV expression that maintains recurrent activation of the RLR-MAVS pathway and
thereby inflammatory activation of MΦ. Thus, we propose a time-course study of the involvement of RLR-
MAVS signaling, IFN-I response and ERV transcription in the short- and long-term effects of gamma IR using
MΦ with knocked out MAVS or IFN-I receptor and in vivo using the wild-type C57BL/6J mice and a MAVS-
knockout strain. The second question is whether IR dose influences the impact of RNA sensors versus DNA
sensors, with respect to the IR-induced DNA damage. We found that increases in IR dose led to a decline in
RLR and MAVS levels, whereas the DNA sensing proteins were consistently upregulated. To test our
hypothesis that high IR doses result in DNA sensing pathway activation and a STING-mediated mechanism
of IFN-I expression that determines MΦ activation, we will investigate the dose-dependent disruption of RLR-
RNA complexes with MAVS, DNA damage and accumulation of DNA fragments and RNA:DNA duplexes to
assess their impact on RLR and STING-TBK1 signaling using MΦ cultures and the indicated above mouse
strains, along with STING-knockout mice. We expect to identify nucleic acid-related signaling mechanism(s)
responsible for the radiation-induced changes in MΦ polarity and their pathological inflammatory activation.

Public health relevance
Project Narrative High doses of ionizing radiation cause profound and chronic inflammation in affected tissues and subsequent fibrosis that is related to the activation and altered polarization of macrophages. Radiation impacts macrophages through DNA damage and the activation of aberrant transcription, which both trigger specific intracellular nucleic acid receptors and downstream signaling pathways, resulting in differential expression of type I interferons and inflammatory modulators. In this project we will explore the distinct role of RNA and DNA sensors and their signaling pathways in prolonged radiation-induced inflammatory activation of macrophages and their response to increasing doses of irradiation.